Molecular structure of the bacterial chemotaxis apparatus

We have been carrying out a sustained and systematic approach to address the challenge of predicting bacterial chemotaxis behavior. In studies reported over the course of the last few years, we have demonstrated that it is possible to directly visualize and determine structures of molecular components of the chemotaxis machinery and cytoskletal components in intact gram-negative bacteria. Our work on direct visualization and spatial organization of chemoreceptor arrays in intact E. coli cells using cryo-electron tomography shows that in wild-type cells, ternary complexes are arranged as an extended lattice, with significant variations in the size and specific location among cells in the same population. In an extension of these studies to C. crescentus, we demonstrated that chemoreceptors in this Gram-negative bacterium are organized as trimers of receptor dimers, forming partially ordered, hexagonally-packed arrays of signaling complexes in the cytoplasmic membrane. This novel receptor organization at the order/disorder interface suggests how receptors and effectors can be packed in signaling assemblies to respond dynamically in the activation and adaptation steps of bacterial chemotaxis. We also used cryo-electron tomography combined with 3D averaging to determine the in situ structure of chemoreceptor assemblies in Escherichia coli cells. These studies represent the first report of structure determination of an integral membrane protein in intact bacterial cells. We demonstrated that chemoreceptors are organized as trimers of receptor dimers and display two distinct conformations that differ principally in arrangement of the HAMP domains within each trimer. Ligand binding and methylation alter the distribution of chemoreceptors between the two conformations, with serine binding favoring the expanded conformation, and chemoreceptor methylation favoring the compact conformation. The fact that we can determine structures of molecular complexes in intact cells revolutionizes our approach to carrying out meaningful calculations of the dynamic changes in the chemotaxis apparatus and cytoskeletal architecture, and to compare how changing the physiology of the cells by genetic alterations can be used to probe and understand the behavior of the underlying complex machinery. In more recent studies, we have further extended the analysis to describe and compare the spatial distribution, localization and architecture of chemoreceptor arrays in three different Gram-negative bacteria using cryo-electron tomography. We show that although each organism shares a seemingly common arrayed architecture, E. coli arrays are disperse and extended, in contrast to the compact arrays observed in Caulobacter and Bdellovibrio cells. Chemoreceptor arrays are also more consistent in size and are closely associated with the single polar flagella in Caulobacter and Bdellovibrio cells, while they vary greatly in size and demonstrate no discernable spatial correlation to the multiple flagella present in E. coli cells. Tomographic averaging results demonstrate that with the application of hexagonal symmetry, all three organisms have a similar unit spacing and trimer-of-dimer distance. However, analysis of receptor distribution in individual arrays reveals substantial variations in nearest neighbor proximities from one species to another, and in response to changes in growth medium. While there are broad variations in size and localization of the chemoreceptor arrays in the different organisms, the packing density of signaling complexes within E.coli chemoreceptor arrays is higher when cells are grown in minimal growth medium as compared to rich medium. We show that these changes in density of packing can be parametrized in the context of an Ising-type model to obtain theoretical predictions for the cooperativity and sensitivity of the cellular response to changes in extracellular ligand concentration. We tested the predictions experimentally using Fluorescence Resonance Energy Transfer (FRET) microscopy to measure CheA activation under conditions identical to those used for the tomographic experiments. The excellent correlation between the predicted and experimentally measured responses demonstrates that knowledge of the molecular organization of the chemoreceptor arrays as determined by cryo-electron tomography can be translated into meaningful computational models for predicting quantitative aspects of the bacterial chemotaxis response.